Formulation toolbox for topically applied drugs to account for physical parameters, dynamic metamorphosis and influence of excipients

Project Summary/ Abstract
Physiologically-based pharmacokinetic (PBPK) modelling has emerged as a valuable tool in
the drug development process for both novel and generic drug products. In particular,
simulation tools can be utilised for generic drug products to assess virtual bioequivalence
between the reference and test products. Dermal PBPK modelling has been applied to the
development of topical formulations by predicting drug absorption into skin in virtual
populations that are constructed using realistic physiology data. It is important to recognise
that topical products undergo changes immediately upon application due to formulation
metamorphosis, which may alter the critical characteristics of the formulations. To accurately
simulate drug permeation through the skin, precise parameterisation of the dynamic changes
that occur during formulation metamorphosis is crucial. A primary objective of this grant
proposal is to improve the formulation parameterisation integrated in the MPML MechDermA
model by integrating dynamic formulation compositions and feedback to critical quality
attributes using advanced prediction methods. The other primary objective is to systematically
verify the model’s predictive capability by assessing its ability to account for variations in drug
product attributes and to predict the influence of these variations on the local bioavailability.
Specifically, Aim 1 will focus on the enhancement of the formulation toolbox by enabling the
input of complete formulation composition data (Q2) and implementing predictive methods to
estimate formulation Q3 properties based on known Q2 characterisation. The proposed
framework will be used in pursuit of Aim 2, wherein individual volatile constituents will be
allowed to evaporate and dynamic re-calculation of formulation Q2 and Q3 metrics
implemented. In addition to evaporation, the depletion of excipient through skin absorption will
be investigated under Aim 3. Commercial and custom desoximetasone drug products
featuring modified formulation attributes will be designed and characterised under Aim 4.
These formulations will serve as challenges for the PBPK models, which will be used to verify
the models’ ability to differentiate between formulation variations and assess
bio(in)equivalence. Aim 5 will focus on the evaluation of skin hydration following formulation
application involving the development and validation of a PBPK model of skin hydration and
absorption of water from topical drug products. Aim 6 will develop a model for simulating
microdialysis and open-flow microperfusion data; this model will be leveraged to simulate
available data on local concentrations in vivo and further verify local concentration predictions.

Public health relevance
Project Narrative This research aims to further enhance and verify performance of the Simcyp Multi-Phase Multi-Layer Mechanistic Dermal Absorption (MPML MechDermA) PBPK model, which has previously been leveraged for approval of a Diclofenac sodium topical gel (Tsakalozou et al. 2021). In vitro characterisation and permeation studies will be designed and conducted within the grant to isolate specific critical quality attributes and verify the model’s ability to differentiate between Q3 similar and Q3 different products. Ultimately, the development and verification of a reliable and robust dermal PBPK model enhanced with the specialized dermal formulation toolbox is expected to aid decision making and result in lower risk, more efficient and cost- effective development of generic drug products providing benefits to patients.